Dynamics of DNA-histone interactions

Project Summary
The overarching goal of my research program is to elucidate the roles of dynamic DNA-histone
interactions in the nucleosome in regulating gene accessibility from single-molecule approaches. The
nucleosome is the fundamental packing unit of genes in eukaryotes and plays important roles in gene
regulation. Errors in gene regulation often lead to developmental failure and lethal diseases such as various
types of cancer. The nucleosome is made of ~147 bp ds-DNA with an octameric histone protein core. DNA and
histones are targets for various chromatin modifications that are often critically implicated in gene regulation
mechanisms. We reported several important changes in the structure and structural dynamics of the
nucleosome induced by various chromatin modifications and histone variants such as DNA methylation,
histone acetylations, SUMOylation, CENP-A, and H2A.Z in the context of their roles in gene regulation. As
these changes are heterogeneous, unsynchronized, and/or complex, they are often impossible to resolve with
ensemble-averaging biochemical, genetic, and static structural biology tools. We develop and improve single-
molecule fluorescence methods and systems, mainly based on FRET, FCS, and colocalization at an optical
super-resolution to address these problems. We will continue pushing the boundaries of these experimental
systems and methods to support our future research that will center around three synergistic themes: how (1)
chromatin modifications and histone variants, (2) spontaneous molecular motions and interactions, and (3)
active and passive molecular machines and enzymes affect DNA-histone dynamics in nucleosomes and
nucleosome arrays and how the effects are implicated in gene regulation mechanisms.
We recently started evolving our mostly nucleosome-focused experimental systems by combining
various enzymes that act on the nucleosome and expanding them to include nucleosome arrays. Based on
these systems, our research will continue largely in three topical areas in the next five years: (1) nucleosome
dynamics during its interaction with complex enzymes such as RNA polymerase II and Dot1L, a key player in
H3K79 methylation-dependent leukemia pathogenesis, (2) the effects of chromatin modifications on the
structure and dynamics of the nucleosome and their implications in nucleosome-enzyme interactions, (3)
conformations and dynamics of nucleosome arrays and the effects of chromatin modifications on nucleosome
dynamics in nucleosome arrays. Investigations in these areas will help understand the fundamental molecular
processes that regulate nucleosome dynamics and gene accessibility during nucleosome-enzyme interactions
in a nucleosome and a nucleosome-array context and at depth and clarity afforded by our highly-refined
tractable single-molecule systems.

Public health relevance
Narrative (Relevance to public health) The proposed research will contribute to elucidating the mechanisms of gene regulation involving nucleosomes and chromatin modifications. Results from this project will help develop diagnoses and treatments of the diseases and disorders associated with erroneous gene regulation such as various types of cancer and neurodegenerative diseases.